Muscular Dystrophy Specialized Research Center

Project 2 Summary
The long-term goal of Project 2 is to define the natural history of the dystroglycanopathies using
established and evolving clinical measures, with the overall objective of optimizing clinical care,
and informing and enhancing clinical trial design. This will be accomplished in 3 Aims. In Aim 1,
we will further our understanding of the natural history of FKRP-related dystroglycanopathy. We
follow a unique cohort of >100 people with a variety of FKRP mutations who range in age from
early childhood through late adulthood. We will expand and extend evaluation of this cohort
using standardized outcome measures. We are particularly interested in people who might be
excluded from clinical trials, such as children and those with advanced disease. We will offer
remote assessments to those with advanced disease, allowing us to relate motor outcomes to
real-world endpoints (e.g. need for respiratory support). In Aim 2, similar methods will be
employed to extend knowledge about the natural history of people with mutations in
dystroglycanopathy genes other than FKRP, based on our current (56 individuals across 8
genotype groups) and growing cohort. We will test outcome measures across phenotypes and
identify cohorts that share similar rates of motor progression who might be studied together in
gene non-specific clinical trials. In Aim 3, we will explore two distinct types of potential
biomarkers. First, we will investigate electroretinogram (ERG) as a candidate
dystroglycanopathy biomarker based on a small pilot study in which we showed altered
photoreceptor function in people with FKRP mutations. We will use an FDA approved handheld
ERG device that allows rapid data acquisition and can be used with children to examine
relationship of ERG findings with motor function. Finally, urine samples collected from study
participants evaluated in Aims 1 and 2 will be utilized for proteomic biomarker assay, starting
with urinary titin (collaboration with Project 1), to determine if change can be detected in concert
with disease progression. Together these aims are highly likely to facilitate clinical trial design
across phenotypes in this group of rare diseases that share the common pathophysiology of -
dystroglycan hypoglycosylation.